Modulation of cancer induced immune suppression via inhibition of SCD1

PROJECT SUMMARY
Metabolic reprogramming plays a critical role in carcinogenesis, in part due its ability to promote immune
suppressive properties within tumors. It remains unclear whether inhibition of fatty acid metabolism in tumors
affects their immunogenicity. We show that inhibition of stearoyl CoA desaturase 1 (SCD1), the rate limiting
enzyme involved in fatty-acid synthesis converting saturated acids (SFA) to monounsaturated fatty acids
(MUFAs), increases the immunogenicity of poorly immunogenic tumors. Our results indicate that inhibition of
tumorigenic de novo lipogenesis represents a novel approach to enhance T cell-based cancer
immunotherapy. In so doing, our novel lead SCD1 inhibitor (MTI-301; aka SSI-4) singly, and in combination with
immune checkpoint inhibitors (ICIs) using immune competent mouse models demonstrates anti-tumor synergy
sensitizing tumors to ICIs, as a prelude to an early phase clinical trial. We will also optimize efficacy and seek
predictive biomarkers of response that could be useful for the design and stratification of patients in the critical
Phase III clinical trial. SCD1 is universally upregulated in aggressive cancers and validated by MTI-301 antitumor
activity across a broad range of cancer cell lines and tumor mouse models. Mechanistically, MUFA deprivation
in addicted cancer cells leads to endoplasmic reticulum (ER) stress mediating apoptotic cell death. We
discovered using immune competent mouse cancer models that MTI-301 activates the adaptive immune
response via calreticulin/PERK arm of the ER stress pathway enhancing activated T cell tumor infiltration and
thereby promoting anti-PD1 antibody therapy. Combined with anti-PD1 inhibitor, MTI-301 sensitizes tumors to
immune checkpoint inhibitors in mouse triple negative breast cancer (TNBC) and HER2 breast cancer mouse
models. Based upon these data, our central hypothesis is that aberrant de novo lipogenesis is linked to
attenuation of tumor immunogenicity. Three aims are proposed in this fast-track Phase 1/2 SBIR proposal. In
Aim 1 (Milestone 1, Phase I SBIR), GLP dog toxicology study will be completed to identify the No-observedadverse-effect level (NOAEL) enabling calculation of the first in human dose for the phase I clinical trial. In Aim
2 (Milestone 2, Phase II SBIR), GMP MTI-301 will be synthesized and capsulated along with submission of the
investigation of new drug (IND) application for FDA Phase I trial approval. In Aim 3 (Milestone 3, Phase II SBIR),
a Phase I clinical trial will be performed and exploratory biomarkers including identification of immune infiltrates
into the tumor site will be assessed. In summary, we envision SCD1 as a broad-spectrum anti-cancer target
overexpressed in aggressive malignancies. Therapeutically useful, MTI-301 increases the immunogenicity of
poorly immunogenic tumors thereby sensitizing to immune checkpoint blockade, leading to dramatic adaptive
immune mediated tumor cell killing. This combination therapy should enhance patient response rates and be
well tolerated in patients.

Public health relevance
PROJECT NARRATIVE A novel fatty acid synthesis inhibitor, MTI-301 (aka SSI-4), sensitizes cancers to immune checkpoint inhibitors. This new therapeutic strategy should increase the number of patients responding to treatment and may lead to cures through prolonged activation of immune T cells in drug resistant cancers.